EFFECT OF PIPERINE ON CYTOCHROME P450 ACTIVITY

That the pungent ingredient of black and long pepers, piperine, modulates the catalytic activity of cytochrome P450, using selective in vivo probes, the effects of acute oral dosing w/piperine, on individual cytochrome P450 (CYP1A, CYP2A6, CYP2C9, CYP2C19,CYP2D6, CYP2E1 and CYP3A) in healthy subjects.